Aberrant chromatin regulatory mechanisms in Down syndrome brain

PROJECT SUMMARY
Down syndrome (DS) is the most common form of autosomal aneuploidy in humans, with an incidence of ~1 in
700 live births, and is characterized by physical growth delays, skeletal abnormalities, neurological deficits and
cognitive impairments. Although the genetic cause of DS is full or partial triplication of chromosome 21 (HSA21),
triplicated genes on HSA21 do not fully account for the widespread transcriptional dysregulation observed in DS.
Given the tremendous amount of variability in the severity and clinical presentation of DS, it has long been
believed that epigenetic processes may also contribute importantly to global patterns of transcriptional
dysregulation, both during neurodevelopment and in adulthood. However, until recently, our understanding of
how chromatin-based mechanisms may contribute to DS-related phenotypes remained limited. During the
previous funding periods of this R01, we found that the HSA21-encoded chromatin effector protein, BRWD1, is
upregulated in neurons from individuals with DS and in brain of both male and female trisomic mice. We
demonstrated that selective copy number restoration of Brwd1 in trisomic animals robustly rescues deficits in
hippocampal LTP, gene expression and cognition. We observed that Brwd1 binds tightly to the mammalian BAF
chromatin remodeling complex – both neural progenitor (np) BAF during development and neuronal (n) BAF in
adulthood – and that increased Brwd1 expression promotes BAF genomic mistargeting. Importantly, Brwd1
renormalization rescues aberrant BAF localization, along with associated changes in chromatin accessibility and
gene expression. These findings established BRWD1 as a key epigenomic mediator of normal
neurodevelopment and an important contributor to DS-related phenotypes. Although Brwd1 is clearly important
for BAF genomic targeting and neural gene expression, the molecular mechanisms through which this targeting
is achieved remains unclear, and the primary neural cell-types affected by Brwd1 triplication in DS-like brain
have yet to be explored. Also, while DS has largely been assumed to be untreatable due to disrupted in utero
development, our recent data suggest that restoring Brwd1 gene activity in early postnatal brain may be sufficient
to ameliorate cognitive deficits in adult trisomic mice, yet the molecular underpinnings and/or importance of
neurodevelopmental timing of this rescue have yet to be explored. Using a unique combination of biochemical,
single-cell omics, genetic and behavioral analyses, we will comprehensively explore: (Aim 1) the biochemical
basis through which Brwd1 recruits the BAF complex to neural chromatin via its histone ‘reader’ functions and
protein-protein interactions; (Aim 2) the longitudinal and cell-type specific contributions of Brwd1 triplication to
BAF genomic targeting, chromatin accessibility and gene expression across multiple brain regions known to be
affected in DS; and (Aim 3) the molecular, physiological and behavioral impact of Brwd1 copy number restoration
during postnatal periods. These studies will provide valuable insights into the molecular mechanisms of Brwd1
dysregulation in DS-like brain and inform on the possibility of postnatal treatments for this disorder.

Public health relevance
PROJECT NARRATIVE Trisomy 21 (Down Syndrome – DS) is the most common genetic abnormality disorder in humans, with an estimated incidence of ~1 in 700 live births worldwide, resulting from triplication of all or part of chromosome 21; however, genetic aneuploidy alone does not fully account for many of the physiological and cognitive deficits associated with this disorder. We previously identified a novel, brain enriched chromatin effector protein, BRWD1, which is triplicated in DS and plays a significant role in the mediation of aberrant patterns of transcription, neurological plasticity and cognitive impairments that define Trisomy 21. Using a unique combination of genetic rescue, behavioral, biochemical, proteomic and epigenomic approaches, we are now mechanistically investigating BRWD1's cell-type specific contributions to neural development and DS associated neurological impairments, with the hopes that such findings will aid in our basic understanding of the molecular phenomena that precipitate DS and inform on the possibility of postnatal treatments for this pervasive disorder